Genetics of Cardiovascular Disease in Chronic Kidney Disease

ABSTRACT
Cardiovascular disease is a main cause of death and disability in individuals with chronic kidney disease (CKD)
but little is known on the genetic factors accounting for the increased cardiovascular disease burden in CKD.
Genome-wide association studies have identified several loci for cardiovascular disease and subclinical
atherosclerosis traits. Studies have also shown that genetic variants that regulate gene expression have
important roles in complex traits. We propose to test regulatory regions of the genome associated with
cardiovascular outcomes using approaches that integrate gene expression data to genome-wide genotypes.
We will use the comprehensive clinical and biomarker data from the Chronic Renal Insufficiency Cohort
(CRIC), a multi-ethnic and longitudinal study of individuals with CKD. CRIC has adjudicated cardiovascular
events in all participants and the study has already documented a high burden of atherosclerosis and
cardiovascular disease in CKD. We will perform genome-wide association studies of cardiovascular outcomes
using dense imputed genotypes from multi-ethnic reference panels obtained from the Trans-Omics for
Precision Medicine (TOPMed) Program to identify new loci in individuals with CKD (Aim 1). To identify putative
causal genes associated with cardiovascular disease in CKD, we will use predicted gene expression
approaches and expression quantitative trait loci from ancestry-matched datasets (Aim 2) and multi-tissues
(Aim 3). This project uses innovative concepts and approaches by integrating transcripts and genotypes for
gene discovery in a high-risk population for cardiovascular disease. This project aligns with NHLBI mission to
reduce the burden of CVD.

Public health relevance
PROJECT NARRATIVE This project will leverage existing clinical, genetic and gene expression data to identify and characterize genetic risk factors for cardiovascular disease in individuals with chronic kidney disease. Findings from this study may provide insights into the biological mechanisms for cardiovascular susceptibility in this high-risk population, which may have implications for precision medicine.